Transcriptomic signatures of airway inflammation in acute respiratory diseases

PROJECT SUMMARY/ABSTRACT: Dysregulated inflammation is a potent driver of acute respiratory
pathology, including acute exacerbations of chronic obstructive pulmonary disease (AECOPD) and the acute
respiratory distress syndrome (ARDS), two conditions with a heavy burden of morbidity, mortality, and
healthcare costs. These conditions are diagnosed by clinical and physiologic criteria that include patients with
heterogenous immune biology, which has resulted in imprecise therapy with limited efficacy. There is a critical
need to understand the heterogeneous inflammatory dysregulation in the lung to develop precision diagnostics
and therapies for these syndromes. This proposal builds on prior work by my mentors that identified specific
inflammatory biomarkers that distinguish subgroups of patients with similar underlying biology, or “molecular
phenotypes” in ARDS and COPD. My co-mentor, Dr. Christenson, identified two molecular phenotypes in
stable COPD distinguished by increases in airway genomic signatures of either enhanced Type 2 (T2) or Type
17 (T17) inflammation. These subgroups exhibit distinct clinical differences, including response to treatment
with steroids. My preliminary data suggest we can extend molecular phenotypes of polarized immune
responses to patients with AECOPD. My primary mentor, Dr. Calfee, identified hyperinflammatory and
hypoinflammatory molecular phenotypes in ARDS based on clinical data and plasma protein biomarkers. The
phenotypes were associated with differences in mortality and response to treatments. The differences in
inflammation in the lung between these molecular phenotypes is not known. Transcriptomic analysis of
samples from the respiratory tract in these patients can identify the role of specific immune pathways in the
pathophysiology that leads to such distinct hyperinflammatory and hypoinflammatory molecular phenotypes.
The overall objective of this proposal is to examine the role of genomic markers of respiratory inflammation in
distinguishing AECOPD and ARDS molecular phenotypes by using transcriptomic data from previously
sequenced airway samples in well-phenotyped cohorts. In Aim 1, we will use sputum sequencing and clinical
data from a cohort of patients with COPD to test for the presence of molecular phenotypes of AECOPD. I
hypothesize there are of molecular phenotypes of AECOPD that are distinguished by expression of
predefined gene signatures of T1, T2, or T17 inflammation during exacerbations. I further hypothesize that
these same signatures in patients with stable COPD will be prognostic biomarkers for susceptibility to
exacerbations in which these pathways are enriched. In Aim 2, I will test for the presence of molecular
phenotypes of ARDS in using RNA sequencing data from tracheal aspirates from an observational cohort. I
hypothesize respiratory tract transcriptional responses will provide insight into the role of the inflammation in
the lung in the pathogenesis of previously described ARDS molecular phenotypes identified by plasma
proteins.

Public health relevance
PROJECT NARRATIVE Acute exacerbation of chronic obstructive pulmonary disease (AECOPD) and acute respiratory distress syndrome are major causes of acute respiratory failure and significant causes of morbidity, morality, and healthcare utilization. Heterogeneous dysregulation of host immune responses is a key driver of pathophysiology in both diseases. The goal of this project is relevant to the NHLBI's Research Priorities to develop biomarkers to predict outcomes and differential responses to therapy in patients with pulmonary diseases.